Duke Training Grant in Digestive Diseases and Nutrition

Enter the text here that is the new abstract information for your application.
The Duke University Division of Gastroenterology has been engaged in the training of clinicians and scientists in gastroenterology and hepatology since 1965. The Aims of our Program are to: 1). Train young investigators and develop future leaders in digestive disease research and 2). Create a community that brings together scientists across our campus engaged in digestive disease research in order to facilitate collaborations and to provide an outstanding training environment. The program offers positions for three postdoctoral fellows for a two-year training experience. The program includes a Basic/Translational Science Track and a Clinical Research Track. Our program includes a mentored research experience in a supportive environment that includes structured mentorship, relevant graduate coursework, and career development guidance. The program provides a research community that stimulates curiosity and offers multiple resources. The program faculty members are 14 MD and 13 PhD faculty from 9 departments at Duke with 17 in the Basic and Translational Research Track and 10 in the Clinical Research Track. The training program faculty have many ongoing and productive collaborations. Our specific aims for this application include: 1) Develop and nurture the pipeline of researchers in digestive diseases from the undergraduate years through medical school, graduate school and postdoctoral training. 2) Identify mentors and organize mentoring teams to support the research training and career development goals of the postdoctoral fellows. 3) Provide a mentored research experience that builds a foundation in research plus career development guidance that will prepare fellows for an independent research career. 4) Offer graduate coursework and seminars that teach fundamental principles to support the research of the postdoctoral fellows. 5) Provide rigorous training in the responsible conduct of research and methods for enhancing reproducibility in research. 6) Guide fellows through an Individual Development Plan to provide each postdoctoral fellow the training experiences that will be needed to prepare the fellow for a successful career. 7) Create a scientific community that celebrates science and disseminates new discoveries through local seminars, visiting scholars and presentations at national meetings.

Public health relevance
Project narrative There is a need for scientists who appreciate the clinical challenges of patients with digestive diseases and then seek to understand the mechanisms of disease. This research training program will provide a high-quality mentored training experience in basic, translational or clinical research. The fellows trained in this program will be prepared for meaningful careers in research that will ultimately lead to new diagnostic tests and therapies for patients with digestive diseases.